Polysubstance Use Symposium

PROJECT ABSTRACT
Polysubstance use is a critical public health concern. Evidence indicates that the majority of persons who use
drugs engage in use of multiple substances which places them at increased risk of overdose. Despite the role
of polysubstance use in the current overdose crisis, it remains an understudied and poorly understood
phenomenon. To accelerate the field of polysubstance use, a “Polysubstance Use Symposium” is proposed to
be held October 20-21, 2022, in New York City, New York. The central location of this major transportation hub
will facilitate the attendance of local and non-local experts, including scholars from major research universities,
policymakers, practitioners, and other interested stakeholders. The 1.5-day meeting includes a keynote
presentation, a series of concurrent research sessions, a poster and networking reception, an early career
investigator mentoring session, a thematic panel, methods workshop, and interactive funding roundtables. The
overall objective of the symposium is to accelerate knowledge of polysubstance use by bringing together an
interdisciplinary group of stakeholders with tremendous potential for a positive impact on the public health
crisis of polysubstance use. The specific goals of the symposium are to (1) increase collaborative efforts
among experts and new researchers of polysubstance use to generate new research aimed at reducing the
public health crisis of polysubstance use, (2) provide a formal opportunity to disseminate cutting-edge research
in the field of polysubstance use as related to three important domains: prevalence and emerging trends,
treatment, and social determinants; and (3) engage polysubstance use researchers in formal networking
opportunities, with an emphasis on generating opportunities for early career and underrepresented
researchers. The symposium will provide actionable information to researchers of polysubstance use, increase
networking among stakeholders to increase innovative research proposals and solutions, and support early
career and underrepresented scholars of polysubstance use in advancing their career goals.

Public health relevance
PROJECT NARRATIVE The United States is in the midst of an overdose crisis that is largely fueled by polysubstance use, yet there are critical gaps in our understanding of this high-risk, yet common, phenomenon. The proposed “Polysubstance Use Symposium” to be held October 20-21, 2022, in New York City, New York will accelerate knowledge of polysubstance use by bringing together an interdisciplinary group of stakeholders, with an emphasis on opportunities for early career and underrepresented researchers. The symposium provides a time-critical opportunity to disseminate cutting-edge research and increase collaborative efforts to generate novel ideas aimed at ameliorating the public health crisis of polysubstance use.